Novel Posttranslational Modifications in Adipose Biology

Project Summary
Metabolic health depends on the maintenance of normal mass and function of adipose tissue (AT).
Accumulation of excess body fat or pathological loss of AT is associated with insulin resistance and
cardiometabolic diseases. White AT (WAT) and brown AT (BAT) act together to maintain a balance between fat
accumulation and energy expenditure. Upstream players that regulate WAT and BAT maintenance remain less
characterized. Ubiquitin (Ub) and Ub-like proteins modify diverse protein substrates and expand the functional
diversity of the proteome. However, the functional role of NEDD8, a novel Ub-like protein that has the highest
homology with Ub, remains poorly understood in the adipose tissue. Neddylation covalently attaches NEDD8 to
target proteins via NEDD8-specific E1-E2-E3 enzymes. Induced adipose deletion of NAE1 (a regulatory subunit
of the NEDD8 E1 enzyme) in mice resulted in loss of adipose tissue potentially through mitochondrial dysfunction
and inflammation. Pharmacological inhibition of neddylation promoted mitochondrial ROS production and
impaired mitochondrial function in mature adipocytes. Interestingly, AT-specific loss of CUL3 (a bona fide
neddylation target) largely phenocopied neddylation deficiency-induced AT loss, and neddylation dominantly
targets CUL3 to modulate mitochondrial function and adipocyte turnover. In BAT, neddylation deficiency causes
BAT atrophy and activation of non-canonical NF-κB signaling. These compelling preliminary data form the basis
of our central hypothesis that neddylation is required for mature white and brown adipose tissue
maintenance through regulation of CUL3-mediated mitochondrial function and/or non-canonical NF-κB
pro-inflammatory signaling. Aim 1 will establish the significance and identify the proteome of neddylation in
regulating mitochondrial dysfunction, adipose tissue remodeling and thus energy balance and adaptive
thermogenesis. Aim 2 will dissect the molecular basis by which neddylation targets a novel mitochondrial
targeted CUL3 E3 Ub ligase to mediate adipocyte mitochondrial activity and turnover thus energy balance. Aim
3 will elucidate a newly identified neddylation target in mediating non-canonical NF-κB signaling to accelerate
brown adipocyte inflammation and turnover. Our proposed study will provide the most in-depth analysis of
neddylation as a hitherto novel post-translational modification essential for both mature white and brown adipose
tissue maintenance. We expect that new findings from this proposal will provide novel insights into our
understanding of the pathophysiology of adipose tissue and its implications on obesity/ lipodystrophy and its
associated metabolic disorders.

Public health relevance
Project Narrative Obesity and its associated metabolic disorders remain major health problems worldwide. This study will address the importance of a novel protein post-translational modification in different fat cell fate, and will investigate how this modification regulates mitochondrial function and inflammatory signaling, all of which are well implicated in obesity and other diseases. This research will also produce broadly applicable, basic biological insights.